Patient Dumping and EMTALA Enforcement Involving Psychiatric Emergencies

Project Summary
Psychiatric emergencies comprise a large and increasing proportion of emergency department (ED) visits, with
many psychiatric patients receiving suboptimal care while boarding in EDs. The Emergency Medical Treatment
and Labor Act (EMTALA) established a duty for hospitals to screen and stabilize patients presenting to EDs
regardless of ability to pay. EMTALA requires that any patient with a medical or psychiatric complaint
presenting to a dedicated ED have a timely screening exam, stabilization of emergent conditions, and transfer
to another facility for a higher level of care if services required for stabilization are unavailable at the original
facility. Hospitals violating EMTALA are at risk for termination of Medicare provider agreements, which typically
results in hospital closure or downgrading of emergency services. Despite potentially grave consequences,
hospitals continue to violate EMTALA. Overall, 17% of EMTALA citations are labeled by the enforcing agency
as involving psychiatric conditions. However, a review of recently available data suggests that these labels
underestimate citations involving psychiatric conditions. Specific conditions and circumstances (e.g., suicidal
ideation, threats to staff) resulting in care denial or outcomes of involved patients (e.g., hospitalization, death,
incarceration) have not been explored. A more rigorous exploration and categorization of individual citations
associated with the care of patients with psychiatric emergencies is warranted to inform care, encourage
compliance, and maintain uninterrupted provision of emergency services. Higher odds of EMTALA citations are
found among hospitals that are large, urban, for-profit, and disproportionately serve Medicaid patients.
However, hospital-level factors associated with EMTALA citations involving psychiatric emergencies have not
been explored. Hospitals with less capacity to care for patients with psychiatric conditions on-site are more
likely to discharge patients compared with hospitals that have greater capacity. Whether the capacity of a
hospital (or lack thereof) to stabilize patients with psychiatric emergencies is associated with risk of EMTALA
citation remains uninvestigated. A multidisciplinary team, including an AHRQ-supported sponsor, co-sponsor,
and key advisors, will provide support and guidance as the applicant develops and completes projects to 1)
identify and characterize EMTALA citation events involving psychiatric emergencies, 2) explore novel
measures of hospital capacity to care for patients with psychiatric emergencies, and 3) evaluate the
association between hospital capacity to care for patients with psychiatric emergencies and receipt of EMTALA
citations. Through didactics and completion of these projects, the applicant will gain experience with 1) health
policy/analysis, 2) qualitative methods, 3) quantitative methods, 4) impactful dissemination of findings, and 5)
writing compelling funding proposals, as he trains to become an independent health services researcher.

Public health relevance
Project Narrative The Emergency Medical Treatment and Labor Act (EMTALA) established a duty for hospitals to screen and stabilize patients presenting to emergency departments with emergent medical or psychiatric conditions regardless of ability to pay. A multidisciplinary team of sponsors, co-sponsors, and key advisors will provide support and guidance as the applicant develops and completes projects to 1) identify and characterize EMTALA citation events involving psychiatric emergencies, 2) explore novel measures of hospital capacity to care for patients with psychiatric emergencies, and 3) evaluate the association between hospital capacity to care for patients with psychiatric emergencies and receipt of EMTALA citations. Through didactics and completion of these projects, the applicant will learn about and gain experience with health policy/analysis, qualitative methods, quantitative methods, impactful dissemination of findings, and grantsmanship, as he trains to become an independent health services researcher.